CORE--ANIMAL AND TISSUE BANK

This core support component of the program project will provide physical services for the Project Leaders and their staff for all participating projects. In addition, the Tissue Bank will provide readily available tissues, both normal and abnormal, to all projects using such tissues. The data base will allow prompt correlations between laboratory projects and clinical outcome. The animal core and labeling studies will provide support for several of the projects.